Deciphering a Regulatory Circuit for Myocardial Metabolism and Energy Homeostasis

DESCRIPTION (provided by applicant): The heart requires highly efficient metabolism to maintain the levels of ATP needed for contractility and pump function. Aberrant cardiac metabolism is associated with obesity, type 2 diabetes and heart failure, which represent major health epidemics. Nuclear hormone receptors and their coactivators and corepressors play critical roles in the control of energy metabolism by regulating the expression of genes involved in energy homeostasis and mitochondrial function. Transcriptional control by nuclear hormone receptors is mediated by the Mediator, a large multiprotein complex that functions as a hub to control gene expression through association with transcriptional activators and repressors. We have discovered that MED13/Thrap1, a component of the Mediator complex, functions as a central regulator of cardiac metabolism and, in so doing, influences cardiac function and metabolic homeostasis in mice. Thus, elevated cardiac expression of MED13 enhances cardiac function and metabolic rate and confers resistance to obesity, whereas MED13 deficiency in the heart causes diminished cardiac metabolism and susceptibility to obesity. MED13 is negatively regulated by microRNAs 208 and 378, which control stress-dependent cardiac remodeling and metabolism. The overall goals of this project are to define the precise mechanisms whereby MED13 and the microRNAs that regulate it control metabolism, energy homeostasis, mitochondrial biogenesis, cardiac stress-responsiveness and phenotypic switching of cardiac and skeletal muscles. These studies will provide important new insights into a previously unrecognized regulatory network for the control of striated muscle metabolism and function, and will open opportunities for therapeutic modulation of metabolic syndromes and muscle diseases through the Mediator-microRNA network. PUBLIC HEALTH RELEVANCE: Dysregulation of cardiac metabolism and mitochondrial function is associated with obesity, type 2 diabetes, and heart failure, diseases with catastrophic cardiovascular outcomes. We have discovered that MED13/Thrap1, a component of the Mediator complex, functions as a central regulator of cardiac metabolism and, in so doing, influences cardiac function and metabolic homeostasis. By defining the mechanisms whereby MED13 controls metabolism and energy homeostasis, we will provide new insights into the regulation of muscle energy metabolism and offer novel therapeutic strategies for modulating these processes in the settings of heart and skeletal muscle disease.

Public health relevance
Dysregulation of cardiac metabolism and mitochondrial function is associated with obesity, type 2 diabetes, and heart failure, diseases with catastrophic cardiovascular outcomes. We have discovered that MED13/Thrap1, a component of the Mediator complex, functions as a central regulator of cardiac metabolism and, in so doing, influences cardiac function and metabolic homeostasis. By defining the mechanisms whereby MED13 controls metabolism and energy homeostasis, we will provide new insights into the regulation of muscle energy metabolism and offer novel therapeutic strategies for modulating these processes in the settings of heart and skeletal muscle disease.